Development of Novel sgp130-Fc Bioconjugates for TBI

ABSTRACT
Individuals with moderate-to-severe traumatic brain injuries (TBI) are at high risk for multiple long-term
complications and poor neuro-recovery. Despite increased knowledge about acute secondary injury cascades,
far less is known about mechanisms underlying the chronic pathology that accompany secondary conditions and
influence TBI outcome. Thus, there is a gap in therapeutics for the chronic, rehabilitation phases of TBI
that support neurorecovery and mitigate risk for secondary conditions. Our published clinical research
suggests that acute cerebrospinal fluid (CSF) IL-6 levels are associated with outcome after severe TBI, and
these temporal IL-6 profiles over the first week identified potential sub-acute and chronic peripheral inflammatory
markers, including IL-6, that associate with long-term functional outcome. Our published work shows that higher
serum sIL-6R during the first 3 months post-injury are associated with worse overall cognitive performance
assessed 6- and 12- months post-injury, yet higher ratios of sgp130/sIL-6R are associated with better cognitive
testing performance indicating a potential protective effect of sgp130 against sIL-6R associated “trans-signaling”.
Depression is also linked to sIL-6R levels, and our clinical data show a moderating effect of sIL-6R on global
outcomes wherein high sIL-6R signaling loads favor a detrimental IL-6 “trans-signaling” environment that we
propose facilitates CNS damage, while low sIL-6R loads favor beneficial classical signaling that we propose
supports neurorecovery. These clinical data suggest that sIL-6R is a modifiable target in the post-acute
rehabilitation phase of TBI recovery for which sgp130 may be a viable treatment that improves outcome.
These clinical research findings are complemented by in vivo studies using the controlled cortical impact injury
(CCI) model of TBI in mice and rats showing sgp130-Fc bioconjugates can reduce cognitive deficits, CNS pro-
inflammatory signaling, and histological damage associated with CCI. However, various mutations and
conjugations of sgp130-Fc, including anti-transferrin receptor (anti-mTfR Oligo) sgp130-Fc bioconjugates, may
facilitate blood brain barrier (BBB) penetration and reduce CNS sIL-6R trans-signaling after TBI. Thus, this SBIR
will focus on proof-of-concept in vitro studies to develop and assess novel sgp130-Fc bioconjugates, with IgG1
mAbs as isotype controls (Phase I), and develop novel anti-TfR Oligo/sgp130-Fc bioconjugates and assess their
effects in vivo using the CCI mouse model of TBI (Phase II). We will select lead bioconjugate candidates by
testing 1° and 2° endpoints for efficacy following treatment in male and female mice after severe CCI. These
include PK assays, microglial activation/uptake, sIL-6R trans-signaling blockade, and treatment efficacy.
Treatment efficacy will be assessed by examining reduced serum/CNS load of pro-inflammatory and CNS
biomarkers, brain tissue sparing, normalization of cellular immunity, and improvements in neurobehavioral
assessments. This work will support future studies developing viable human sgp130-Fc bioconjugates for
clinical, rehabilitation phase treatment after moderate to severe TBI.

Public health relevance
NARRATIVE Given the dearth of effective neuroprotective or neuroreparative treatments for TBI, this study carries great public health relevance in that it aims to establish novel sgp130-Fc bioconjugate agents as effective immunotherapies that facilitate neurorecovery in the post-acute phase of TBI and reduce risk from the many secondary conditions (e.g., cognitive dysfunction, mood disorders) linked to homeostatic disruptions in immune function after TBI. We have leveraged a reverse translational approach, grounded in clinical biomarker data, to identify sIL-6R signaling as a potential therapeutic target, and the benefits of sgp130-Fc observed in our pilot data in experimental TBI support the rationale for the study design and goals proposed, which aim to inform future TBI clinical trials with sgp130-Fc bioconjugates that are both compatible and safe for human use.